Sexual network structure and HIV testing and treatment: understanding the implications for ending the HIV epidemic.

PROJECT SUMMARY
The global HIV pandemic has had an enormous impact on human health, with 39.9 million people living with
HIV and 1.3 million new infections in 2023. Despite clear evidence at the couple-level that HIV test-and-treat
strategies are successful at reducing HIV transmission, population-level trials have shown mixed effectiveness
of test-and-treat strategies to reduce HIV incidence. There is evidence of disparities in testing and treatment
engagement. Furthermore, these disparities are frequently along the same characteristics as sexual network
clustering. Therefore, a potential explanation for a smaller than expected incidence impact is sexual network
clustering, partnering of like-with-like, by HIV testing and treatment. Indeed, my preliminary work showed that
couples in South Africa who reported never testing for HIV were nearly 2 times more likely (1.9, 95% CI=1.8-
2.0) to be partnered with one another than expected by random chance. But this finding needs replication, as
there is little empirical evidence to support these claims. Through network analyses and simulations,
contextualized with community interviews, this career development award will assess whether sexual network
clustering impacts the effectiveness of HIV treatment as prevention. These results will inform population-level
treatment targets. Further, they will allow me to test the utility of network-driven strategies to drive testing and
treatment and provide clear guidance to maximize the impact of these interventions. Analyses of rich data in
sub-Saharan Africa (SSA) will allow for inference to domestic settings in the USA. Research aims will include:
1) Identify the network context of HIV test-and-treat interventions in SSA by (A.) Characterizing the sexual
network position of people engaged in test-and-treat, and (B.) Estimating the level of sexual network clustering
by test-and-treat; 2) Evaluate the impact of network-driven strategies of HIV interventions using network
models parametrized with data on engagement in HIV test-and-treat and sexual network context; 3) Translate
modeling and network analyses to real-world settings. This proposal will leverage previously collected data
from Uganda, Malawi, and Nigeria: the Rakai Community Cohort Study, the TRUST/RV368 Study, Populationbased HIV Impact Assessments, and the Likoma Network Study, and collect original qualitative data in Rakai,
Uganda. This work will build on my existing global collaborations, while developing my expertise in network
science and translation through a mentorship team with extensive experience in network data collection and
conducting community-informed work. Building on these findings, future funding will be sought to collect
expanded sexual network data and develop network-level intervention strategies. My training plan will include
gaining experience in participatory modeling and qualitative work, a novel skillset among network modelers.
This career development project will provide me with expertise to begin an independent career as a leader in
HIV and sexual network research.

Public health relevance
Despite clear evidence at the couple-level that HIV test-and-treat strategies are successful at reducing HIV transmission, population-level trials have shown mixed effectiveness of test-and-treat strategies to reduce HIV incidence. Through network analyses and simulations, contextualized with community interviews, this career development award will assess whether sexual network clustering impacts the effectiveness of HIV treatment as prevention in comprehensive existing datasets, for efficiency, to help us better understand situations where the population-level impact of test-and-treat strategies are successful and where they are not. These results will inform population-level treatment targets and will allow tests of the utility of network-driven strategies to drive testing and treatment, providing clear guidance to maximize the impact of these interventions in the United States.